Monitoring neoadjuvant chemotherapy of breast cancer using 3D subharmonic aided pressure estimation

Abstract
There is no change from the current project period.
Project Summary/Abstract

Public health relevance
Narrative There is no change from the current project period. Project Narrative